Advancing Conformance with the Voluntary National Retail Food Regulatory Program

Project Summary/Abstract TDH, GEH devised four goals. These four goals address how the funds requested from announcement RFA-FD-12-011 will be utilized in achieving conformance with The Voluntary Retail Food Program Standards. During our self assessment of our current Retail Food Program, we found that portions of the Standards had been met, however only Standard 7 was met in its entirety. The other standards have not been met by our organization and require modification in order to align with the Standards minimum requirements. The four goals address how our organization will achieve those Standards. The first goal addresses Standard 2. We found that our current training program requires some modifications to obtain Standard 2. Attainment of Standard 2 is our highest priority. It is essential to this organization and the population it serves, to have a highly qualified workforce. Therefore, the majority of award funding in the first two years will be utilized to implement Standard 2. The second goal is to increase efforts of the organization to improve upon and implement policies and procedures to ensure conformance with the remaining Standards. The third goal addresses establishing and maintaining key stakeholder relationships, including industry consumer groups, academia, and governmental agencies. The final goal addresses program monitoring and reporting. Purpose of Standard 2 implementation: The intent is to develop a skilled staff that is able to conduct proper inspections.

Public health relevance
Project Narrative Proper training and use of Standard 2 will provide our Environmentalists the necessary skill set to conduct risk-based inspections with a priority on foodborne illness prevention. They will be able to use this training to educate the establishments so retail food service operators will be better informed of causes of foodbone illnesses and preventative measures. By working together with the establishment owners, the citizens and those visiting Tennessee will be better protected. __SpecificAimsTextDelimiter__ Specific Aims TDH, GEH will achieve four goals. The first of these will be to implement policies and procedures in Tennessee towards meeting Standard 2 of FDA's Retail Program Standards. All environmental specialists will be required to successfully complete the following steps: 1. Completion of curriculum courses designated as "Pre" in Appendix B-1 prior to conducting any independent routine inspections. 2. Completion of a minimum of 25 joint field training inspections, 3. Completion of a minimum of 25 independent inspections and the remaining course curriculum (designated as "post" courses) outlined in Appendix B-1. 4. Completion of a standardization process similar to the FDA standardization procedures. 5. Completion of 20 contact hours of continuing food safety education every 36 months after the initial training is completed. After completion of the training, TDH, GEH will have a highly qualified workforce that would effectively perform inspections and provide training to establishments on the management and prevention of foodborne illness risk factors. This training will begin in January, 2013 and will be complete December, 2014. In January 2015, training of Standard 3 will begin. The second goal will be to form a committee for implementation of VNRFPS. Members of this committee will include Tennessee Dept of Agriculture, Contract Counties, and other key stakeholders from the government and/or industry. The committee will encourage uniformity and conformance with the Standards. This committee will meet at least bi-annually. The committee will be formed by March, 2013 and will have its first meeting in May, 2013. The third goal will consist of continued participation on committees such as the Food Safety Task Force, Tennessee Public Health Association, and the Food Code Committee. Included in these meetings will be the sharing of best practices and engaging the retail food industry to promote effective management and prevention of foodborne illness risk factors. These committees will meet multiple times annually. The reporting of the progress of this strategic plan along with any additional information required/requested by the FDA is the final goal. This will include a calendar of standardization planning/training and the completed copy of TDH, GEH Training Policy Manual which will be modeled after the CFP Training Manual. Proper training and use of Standard 2 will provide our Environmentalists the necessary skill set to conduct risk-based inspections with a priority on foodborne illness prevention. They will be able to use this training to educate the establishments so retail food service operators will be better informed of causes of foodbone illnesses and preventative measures. By working together with the establishment owners, the citizens and those visiting Tennessee will be better protected.